Epidemiology and Pathophysiology of Acute Pancreatitis-related Diabetes Mellitus

Project Summary/Abstract
Acute pancreatitis is a common inflammatory disorder with short- and long-term clinical
sequelae. The development of diabetes mellitus following an episode of acute pancreatitis
(termed AP-related DM) is now recognized in approximately 25% of patients; however, its
epidemiology and pathophysiology remain poorly characterized. These knowledge gaps limit
our ability to identify which patients are most likely to develop this metabolic complication and
design targeted prevention and treatment strategies. Therefore, we have developed a
prospective, longitudinal, observational cohort study in AP, along with a series of hypothesis-
driven investigations in AP-related DM. We propose The Ohio State University Clinical Center
(OSU-CC), an innovative, strategically aligned, multi-disciplinary team of nationally-recognized
experts to address knowledge gaps in AP-related DM and work collaboratively with other
selected Clinical Centers within the framework of the NIDDK to form the Type 1 Diabetes in
Acute Pancreatitis Consortium (T1DAPC).

Public health relevance
Project Narrative The development of diabetes mellitus following an episode of acute pancreatitis (termed AP- related DM) is now recognized in approximately 25% of patients; however, its epidemiology and pathophysiology remain poorly characterized. The Ohio State University Clinical Center (OSU- CC) has developed a prospective, longitudinal, observational cohort study in AP, along with a series of hypothesis-driven investigations to address knowledge gaps in AP-related DM.